Mass Spectrometry Molecular Imaging and Multi-Omics

PROJECT SUMMARY/ABSTRACT
The Sidney Kimmel Comprehensive Cancer Center (SKCCC) Mass Spectrometry Molecular Imaging and
Multi-Omics (MSMIMO) Shared Resource (SR) integrates three cooperative facilities across Johns Hopkins:
the Applied Imaging Mass Spectrometry (AIMS) facility, the Mass Spectrometry and Proteomics (MSP) facility,
and the Metabolomics unit. The MSMIMO SR offers innovative, integrated multiomic workflows that combine
omic technologies for systems biology analysis of cancer cells and tissues using state-of-the-art and novel
mass spectrometry-based technologies for molecular tissue imaging (spatialomic), metabolomic and proteomic
strategies to accelerate cancer research. AIMS offers rapid matrix-assisted laser desorption/ionization (MALDI)
imaging of a variety of biomolecules, including endogenous peptides, proteins, N-glycans, lipids, metabolites,
and drugs or drug metabolites in cancer cells, spheroids, organoids or tissue sections at high spatial resolution
(5 micron). The MSP Facility offers proteomic labeling and label-free strategies, including multidimensional
protein identification technology, parallel reaction monitoring, tandem mass tags and stable isotopic labeled
amino acids in cell culture for identification and relative or targeted quantification of novel therapeutic proteins,
modifications or pathways, dysregulated in cancers, and for tracking interactions of these targets during
changes in signal transduction or formation of protein complexes. The Metabolomics Unit offers high
throughput detection and quantification of polar and nonpolar metabolites in tissue or fluid extracts. MSMIMO
SR services include experimental design, tissue sectioning, sample preparation, buffer exchange, proteolysis,
labeling, derivatizations, chromatography, MALDI imaging, tandem mass spectrometry imaging, image
analysis, two-dimensional nanoflow liquid chromatography tandem mass analysis, data analysis and
interpretation, and assistance with reporting results, training and data submission to public repositories.
Biostatisticians and Bioinformaticians are available for in-depth statistical analyses of spatialomic, metabolomic
and proteomic results. The MSMIMO SR provides access and training to proprietary software and equipment
for SKCCC investigators who wish to perform their own analysis and offers workshops on operating user-
accessible mass spectrometers several times a year. The MSMIMO SR's innovative approaches and
workflows provide SKCCC Members with the spatial resolution to compare metabolomes, drug metabolism,
lipidomes and proteomes across individual cells or cell clusters within the tumor microenvironment. Our
comprehensive, highly multiplexed molecular discovery platforms are designed to advance Center Members'
research by revealing molecular networks that drive tumorigenesis. During this funding period, 63 SKCCC
investigators have used the MSMIMO SR, and more than 30 manuscripts are attributed to this SR.
SKCCC Managed Shared Resource
Reporting Period: January 1, 2020 to December 31, 2020